Understanding the role of Tmc proteins in hair cell mechanotransduction of zebrafish

PROJECT SUMMARY
The zebrafish model system has effectively offered insights into the molecular mechanisms of hearing, deafness,
and hair cell function. Its success partly lies in the morphological and genomic similarities related to hearing
between zebrafish and mammals. Explicitly, at the cellular level, the morphology of the hair cell is similar and its
signature organelles are conserved. In mammals and zebrafish, the hair bundle has stereocilia of graded heights.
At the molecular level, the stereocilia are joined by tip links to permit mechanotransduction. Numerous genes
that when mutated cause deafness in humans or mice, also cause deafness or hair cell dysfunction in fish.
Mutations in TMCs cause deafness forms DFNB7/11 and DFNA36 in humans and defects in the hair cells of the
lateral line and ear in zebrafish. Studies on mouse and zebrafish Tmcs indicate that different hair cell-containing
organs require different Tmc proteins or combinations of Tmc proteins to carry out their specific task in receiving
and encoding different types of mechanical stimuli. Moreover, hair cells within the same organ can have different
Tmc requirements. For instance, some hair cells within a lateral line neuromast organ require Tmc2a and others
require both Tmc2a and Tmc2b; this indicates that these proteins may work together for mechanotransduction
and this could change the quality of this process. Moreover, there is evidence that all Tmcs are not equivalent.
How the organs differ in terms of the Tmcs that they express and require for functioning and the reasons for
these differences are currently unknown. Here, we will examine the roles of Tmcs in hair cell
mechanotransduction in zebrafish. In Specific Aim 1, we will determine if Tmcs contribute differently to zebrafish
hearing. In Specific Aim 2, we will determine the role of Tmcs in hair cell mechanotransduction and lateral line-
mediated behavior. In Specific Aim 3, we will determine whether Tmcs interact in vivo. These studies should
allow a deeper understanding of how hair cells use particular Tmcs to encode stimuli for hearing and behavior.

Public health relevance
PROJECT NARRATIVE Detection of sound, angular and linear accelerations, and water motion rely on mechanotransduction complexes at stereocilia tips. Three different Tmcs play roles in these senses in zebrafish, but their specific functions are unknown. Here, we will develop an understanding of how hair cells and the particular Tmcs they express are used to capture and encode different stimuli in different organs and similar stimuli within the same organ.